Assessing the feasibility and acceptability of a Time Restricted Feeding intervention among older adults with Mild Cognitive Impairment

Obesity and related metabolic comorbidities have been associated with more than a 4-fold increased risk of
incident cognitive impairment, including Alzheimer’s disease and related dementias (ADRD). Dysfunctional
metabolic flexibility is increasingly recognized as a critical mechanism linking metabolic risk factors to risk of
cognitive impairment, although few studies portable behavioral strategies to enhance metabolic function among
individuals at risk for ADRD. The present study will examine the feasibility and acceptability of a 12-week time
restricted feeding intervention among individuals with mild cognitive impairment (MCI). Changes in cognitive and
metabolic function will also be examined.

Public health relevance
Project Narrative: This proposal responds to PAR-21-360 by examining the feasibility and acceptability of a time restricted feeding intervention among obese older adults with mild cognitive impairment. This one-arm trial will also examine preliminary changes in cognitive and metabolic function.